Contribution of Glia to Sleep/Wake Disturbances in FXS

Sleep impairments are commonly reported in Fragile X syndrome (FXS) and autism
spectrum disorders (ASD). Sleep impairments can have profound negative impact on
brain development, cognition and general well-being however the underlying brain defects
of sleep impairments in FXS are not well understood. While most research of sleep
mechanisms have focused on neurons, recent studies revealed a critical role of
astrocytes, a type of glia in the brain, as regulators of sleep and wake. Specifically,
astrocyte Ca2+ signals exhibit distinct features across the sleep-wake cycle, are reduced
during sleep compared to wakefulness and manipulating astrocyte Ca2+ signaling impacts
sleep. Astrocytes in FXS have hyperexcitable Ca2+ signaling in culture and our preliminary
data demonstrate the same in vivo. The goal of this proposal is to investigate the
contribution of astrocytes and especially increased astrocyte Ca2+ signaling, to sleep
impairments in FXS. We will ask the following important questions: How is sleep
architecture impaired in FXS mouse models across development and adulthood and what
is the contribution of astrocytes? In Aim 1 we will perform longitudinal telemetry to measure
brain rhythms and behavior to determine the sleep architecture in the Fmr1 KO mice. To
identify the contribution of astrocytes we will also record from astrocyte specific Fmr1
deletion (cKO) and restoration (cON) mice. Next, we will ask how is astrocyte Ca2+
signaling altered during sleep-wake cycle in FXS mouse models? In Aim 2 we will record
cortical astrocyte Ca2+ activity with 2-photon microscopy in awake and naturally sleeping
mice while monitoring brain rhythms and behavior. We will also image the dynamics of
norepinephrine (NE) and NE-projections in the cortex. Finally, in Aim 3 we will determine
the causal relationship between altered astrocyte Ca2+ signaling and sleep impairments
using genetic and chemogenetic approaches and determine the impact on sleep-
dependent synaptic plasticity. The approach is intellectually and technically innovative as
a first study to link FXS sleep deficiency and altered cortical astrocyte Ca2+ activity and
because it employs a novel combination of state-of-the-art approaches. The proposed
research is significant because it is expected to provide critical knowledge of the molecular
and cellular mechanisms by which sleep impairments are regulated in FXS. Ultimately,
such knowledge is expected to guide the development of astrocyte-specific therapies for
treatment of sleep impairments in FXS and autism spectrum disorder.

Public health relevance
Sleep impairments, commonly reported in Fragile X syndrome (FXS), can have profound negative impact on brain development, cognition and general well-being. While most research of sleep mechanisms have focused on neurons, recent studies revealed a critical role of astrocytes, a type of glial cell in the brain, as regulators of sleep and wake cycle and here we will examine their role in sleep impairments in FXS. These studies could identify astrocyte-specific therapies for treatment of sleep impairments associated with FXS.